PPAR RECEPTORS IN MECHANISM OF ACTION OF TROGLITAZONE

Determine if troglitazone leads to an induction of skeletal muscle PPARy receptors and to measure the effect of troglitazone on insulin stimulated glucose disposal.